Role and Regulation of Asparagine in Colorectal Cancer

Project Summary
We propose to address the causal link between Asn and sex-specific differences in colorectal cancer (CRC)
tumor growth. We have compelling preliminary data which shows sex-specific metabolism in CRC, whereby
tumors from female patients have a nutrient deplete metabolic phenotype characterized by increased asparagine
(Asn) production, and a positive association between elevated Asn and poorer prognosis for females only. We
show that asparagine synthetase (ASNS), the enzyme that catalyzes Asn production within the tumor, is
positively associated with female patient prognosis and specifically for stage III-IV patients. Knockout of ASNS
in CRC cells and xenograft in mice results in smaller tumor volume for female mice, and longer tumor-specific
survival. We have identified a potential mechanism for this sex-related difference through an estradiol-mediated
stress response, which activates G-protein coupled estrogen receptor 1 (GPER1) signal transduction and ASNS.
ASNS and GPER1 are part of a coordinated response to a nutrient stressed tumor microenvironment that
increase cell survival and tumor growth, i.e. at advanced stages of cancer growth. Even though the canonical
relationships that link GPER1 and ASNS are well established, the association between GPER1 and ASNS and
their effects on cancer growth are novel. Moreover, GPER1 associates with poorer survival in female stage III-
IV patients, and not males, supporting the sex-specificity of GPER1 in advanced CRCs. In addition to intracellular
production of Asn, Asn can be taken up by the tumor from exogenous sources (i.e., diet, microbiome). We show
that Asn supplementation to ASNS knockout CRC cells rescues depleted growth, and analysis of cecal contents
from 100 germ-free mice inoculated with distinct microbiota show that they can metabolize Asn, thus could
contribute to Asn supply in the colon for tumor growth. Therefore, we hypothesize that: intracellular (GPER,
ASNS) and extracellular (microbiota and diet) regulation of Asn contribute to CRC growth in a sex-
specific manner. In Aim 1 of this proposal, we will use samples from two large clinical cohorts to determine
whether ASNS and GPER1 act as sex-specific prognostic biomarkers in male and female patients with advanced
stage CRC, we will also examine stool from CRC patients to identify microbiota that are Asn consumers or
producers and determine how treatment for CRC modulates Asn-metabolizing microbiota. In Aim 2 we will
determine how GPER1 and ASNS promote CRC primary tumor growth and metastasis in colonoscopy-guided
orthotopic mouse models in a sex-specific manner. In Aim 3, we will determine the impact of dietary Asn on sex-
specific differences in CRC growth and use gnotobiotic CRC mouse models inoculated with microbiota that
express ASNS, to determine whether microbial production of Asn directly contributes to cancer growth. In this
proposal, we have a high level of innovation, using colonoscopy-guided orthotopic models, assessments of sex-
differences, and translation using large clinical cohorts. We anticipate that we will be able to translate such
knowledge to target this patient subgroup and improve clinical outcomes.

Public health relevance
Narrative Colorectal cancer is the third leading cause of cancer deaths in the United States. The proposed study will determine the intracellular and extracellular production of asparagine and its sex-specific causal relationship in CRC development. Such understanding will provide important insight into how sex-specific differences contribute to tumor growth in colorectal cancer.